Targeting a novel glyco-immune checkpoint for cancer immunotherapy

Targeting a novel glyco-immune checkpoint for cancer immunotherapy
ABSTRACT:
Immunotherapies have revolutionized cancer treatment in recent decades, but most patient responses are of
limited duration, and primary or secondary resistance is the norm. There is an urgent need to identify additional
immune checkpoints and develop inhibitory drugs to allow immune attack of established tumors.
Checkpoints typically function through cell-cell contact between ligand-receptor pairs, so identifying novel
interactions is of great benefit. To this end, we constructed a protein library comprising the extracellular domains
of 512 molecular species from IgSF and TNFSF families for specific protein-protein interaction screening. Using
these techniques, we identified the novel interaction between IgSF members VSIG4 and Siglec-7. Of note, these
proteins diverge significantly from non-primates.
Our data implicate Siglec-7 as an innate immune inhibitory receptor for NK cell activation, suggesting that the
Siglec-7-VSIG4 interaction functions as an immune checkpoint. Here we propose to develop in vivo models to
elucidate the mechanisms of function of these novel human-specific interactions. We will utilize our humanized
mouse platform, MISTRG6-A2, which affords us the opportunity to manipulate innate (and adaptive) immune
cells in vivo. Given the overexpression of VSIG4 on multiple myeloma (MM) cells (especially after lenalidomide
treatment) and acute myeloid leukemia inv(16) cells (AMLinv(16)), we will explore the impacts of the Siglec-7-
VSIG4 checkpoint on these malignancies in vitro and in vivo.
Completion of these aims will enhance our understanding of immune activation and tumor immuno-evasion, as
well as pinpoint the disease(s) most relevant for future clinical development of immune checkpoint inhibitory
antibodies. Intervening on novel checkpoints will open the door to new therapies with the capacity to improve
patient outcomes in MM and AMLinv(16), with potential applicability across many other tumor types.

Public health relevance
PROJECT NARRATIVE: We identified a mechanism for controlling whether natural killer immune cells kill malignant cells. In this project, we will use patient samples from a biobank to test how this checkpoint works in a humanized mouse. With genetics and new drug compounds we will reactivate natural killer cells to control cancer growth.